A novel low-cost and noninvasive device to measure deep temperature in the body

DESCRIPTION (provided by applicant): Abstract By noninvasively measuring temperature distributions at depth, we could provide new vision of thermal processes occurring in tissues well below the skin surface. An instrument with such ability would respond to many clinical needs, including the monitoring of brain status during cardiac surgery, detect abnormal metabolism in the early formation of aggressive breast cancer, and observe the inflammatory processes in arthritis. Microwave radiometry has been used for many years in astronomy to observe temperature of stars far away. Recent advances in microwave electronics have produced ultra-low noise amplifiers, multilayer compact antennas, and ultra-precise analog-to-digital converters which provide powerful new capabilities for radiometric detection and for the miniaturization of such devices. The proposed instrument development combines these elements to develop a novel array of miniature microwave sensors that will reliably and noninvasively detect small fluctuations in heat emission from deep below the surface of skin. A multidisciplinary team will implement an array of compact, ultrasensitive microwave radiometers mounted directly on deep penetrating antennas. With real-time correlation of radiometric signals from multiple antennas and frequency bands we will reconstruct the thermal distributions at depth several cm below the sensors. We will then demonstrate its potential use in medicine, by comparing in ten patients the head thermal profiles obtained noninvasively by a miniature radiometric array prototype with invasive temperature sensors currently used for long-term monitoring of brain status with traumatic injuries. The proposed thermal imager will enable noninvasive detection of thermal phenomena, such as tumors metabolism in breast tissue or inflammatory response deep below the skin with capabilities that extend far beyond current technology and give us an innovative tool for medical applications.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): This project seeks to develop a low-cost microwave device that safely and noninvasively measure tissue temperature deep below the skin surface. Being safe and comfortable, it has the potential to become an important instrument for many medical applications, from long-term monitoring of brain temperature to early diagnosis of aggressive breast cancer, from detection of arthritic inflammation to assessment of disease progression and response to therapy. Intrinsically affordable, it can be also used in low-resource settings. It will ultimately help in better understanding sub superficial thermal processes, such as cancer metabolism and inflammation.